Human iPSC-Based Personalized Cell Therapy of PD

Abstract
Parkinson’s disease (PD) is the second most common neurodegenerative disorder after Alzheimer’s disease,
affecting 1-2% of the population over the age of 65. With our aging population, it is anticipated that the burden on
our society will significantly escalate. Currently, there are no treatments that can halt or reverse the progression
of PD. Because the loss of a specific cell type, midbrain dopamine (mDA) neurons in the substantia nigra, is the
main cause of motor dysfunction in PD, it is a promising target for cell-based therapy. Indeed, numerous studies
have demonstrated the proof-of-principle that cell transplantation is a viable therapeutic regimen for PD once
unlimited, functional, and safe cell sources can be established from different individuals with varying genetic
backgrounds. Among various potential cell sources, patient-derived human induced pluripotent stem cells
(hiPSCs) represent a promising cell source and may permit personalized cell therapy without ethical or medical
issues such as immunosuppression required for allogeneic cell transplantation. Toward this long-term goal,
during the last decade, we have uncovered a novel molecular pathway underlying metabolic reprogramming,
identified specifically involved microRNAs, developed a chemical method to eliminate remaining undifferentiated
cells with tumorigenic potential, established novel reprogramming methods to generate clinical grade iPSCs and
in vitro differentiation methods to generate healthier mDA cells, and improved neurosurgical methods to increase
the graft survival, leading to the first autologous cell therapy for a sporadic PD patient. At the same time, our
progress revealed several fundamental and practical challenges that must be addressed to realize fully the
potential of hiPSC-based autologous cell therapy for PD, including further development of more robust and safer
reprogramming and in vitro differentiation methods based on molecular mechanisms underlying metabolic
reprogramming during cell fate regulation. We propose to address these fundamental and practical issues of
patient-specific cell therapy and to establish a platform that will enable personalized cell therapy for PD patients
regardless of their genetic backgrounds.

Public health relevance
Narrative The “induced pluripotent stem cell (iPSC)” technology is a promising method that can enable personalized autologous cell therapy of Parkinson’s disease (PD) and other degenerative human diseases. To realize the potential of using iPSCs in personalized cell-based therapy for PD, based on our promising pre-clinical as well as clinical studies, we propose to further improve the safety and efficacy of reprogramming and in vitro differentiation technologies. This proposal will provide a standardized method for generating and characterizing clinical grade human iPSCs and transplantable dopamine cells, leading to a platform that will enable personalized cell therapy for PD patients regardless of their genetic backgrounds.